Enamel atlas: systems-level amelogenesis tools at multiple scales

ABSTRACT
Enamel defects, whether congenital, acquired, or environmental in origin, are associated with a significant cost
to society and also have profound psychological impacts. Despite significant progress over the last decade, the
developmental process that gives rise to enamel, known as amelogenesis, remains poorly understood. We have
identified at least two factors that have delayed progress, and which we propose to address in this application.
One is that existing mouse reagents, which provide the primary model for understanding genetic regulation of
amelogenesis, have deficiencies that hinder dissecting the mechanisms in vivo. Another challenge is that new
information regarding the nanostructure and phase composition of enamel have begun to emerge that prior
models did not take into account. The ability to access powerful new genetic approaches, “omics” techniques
and materials characterization methods therefore creates unprecedented opportunities to generate sophisticated
new tools that will help push amelogenesis research to the next level.
We propose to take full advantage of these recent technical advances and of the complementary expertise of
our team to create an integrated, multi-modal set of tools and reference materials. Specifically, we will generate
innovative mouse reagents, including amelogenesis-stage specific Cre drivers, reporters and conditional
knockout and knock-in models of key structural and proteolytic players that constitute the enamel matrix, which
will enable a workflow to profile transcription (using RNA sequencing) and translation (using proteomics) at
specific developmental stages, and even on a single cell basis (using single-cell RNA sequencing). Tissue and
cell-level molecular profiling will be complemented by an in-depth characterization of the structure, composition,
and mechanical properties of forming and mature enamel at overlapping length scales. By mapping gene
expression, specifying local proteomes, and quantitatively assessing impact of the perturbations at each of these
levels on the materials properties of enamel, we will create a platform that will empower amelogenesis
researchers, help delineate mechanisms of disease, and lay the groundwork to enable the development of new
approaches of intervention.

Public health relevance
PROJECT NARRATIVE Defects in tooth enamel are associated with a multitude of health conditions, and although significant progress has been made in our understanding of enamel formation, many crucial questions remain unanswered. We will produce a toolkit of genetic mouse reagents and will use advanced materials characterization techniques to generate an atlas of the process of enamel formation. This platform will empower enamel researchers, help delineate mechanisms of disease, and enable the development of new approaches of intervention.